Retrovirus models of cancer P01CA100730 Diversity Supplement

Project Summary/Abstract
No changes from originally proposed project.

Public health relevance
Project Narrative No changes from originally proposed project.